WF DISC: Navigating Data Solutions for Chronic Pain and Opioid Use Disorder

PROJECT SUMMARY
The multidimensional challenge of opioid overdose prevention requires solutions larger than a single network
project. While the HHS and NIH are focusing on developing prevention strategies from numerous perspectives,
blending these data will require complex data solutions to move beyond siloes. While we do not know yet how
bringing the elements of opioid overdose data together will be most effective, collecting these data in ways that
allow for FAIR (Findable, Accessible, Interoperable, Reusable) formatting builds toward that potential. The goal
of the HEAL D2A program is to develop opioid overdose surveillance in real time, but it going to take significant
combined clinical and informatics knowledge to bring this system together. To accomplish this goal, our
proposal is responsive to RFA-DA-22-052 to design flexible and creative informatics solutions for the HEAL
Data2Action program (HD2A) network. The WF Data Infrastructure Support Center (DISC)'s highly qualified
clinical informatics team will provide direct support, guidance, and assistance to ensure that data
infrastructures of the highest quality are produced in the shortest possible time for the HEAL D2A Innovation
Projects. Our overall goal as a U24 Data Center is to identify and eliminate data infrastructure barriers
(knowledge and technical) to allow successful completion of the HD2A projects. The objective of this proposal
is to navigate the expected and unexpected data challenges for the HD2A network, encompassing the
Innovation projects to identify tools, provide data support, and deliver training assistance. We will accomplish
this objective through successful completion of these phased aims. To support the overall hypothesis of the
HEAL D2A network, in Aim 1, the WF DISC's Study Start-up Core will identify and develop data infrastructure
support and tools. In Aim 2, WF DISC's Study Conduct Core will work with the HD2A RASC and MERC
provide data measurement, analytical, and visualization support and coordination. In Aim 3, The WF DISC's
Study Dissemination Core will develop and provide data training and resources. In Aim 4, we will identify rapid
data infrastructure modernization support (Rapid DIMS) needs and provide programmatic resources. At the
successful completion of the proposed research, the expected outcomes are centralized support, resources,
and coordination of all data-related needs for the HEAL HD2A Innovation Projects. The proposed research is
innovative because adaptation of our team's experience will bridge clinical research and informatics
infrastructure to provide logistical, scientific, oversight, and technical support for data collection, curation,
reporting, and management by the HD2A Innovation Projects. These results will provide a strong basis for
further/future development of opioid overdose prevention surveillance, which is expected to have a significant
impact on overdose by allowing for rapid intervention and pivoting of resources. This research aligns with NIH
NIDA and HEAL's goals to prevent and mitigate the impact of the OUD epidemic.

Public health relevance
PROJECT NARRATIVE This project is relevant to public health because it builds the infrastructure to transform opioid overdose prevention for our nation. This work will support novel HEAL D2A Innovation Projects goals for creating data sources poised to support real time data that can be used to improve our prevention strategies. This aligns with HHS and NIH NIDA's mission to prevent and mitigate the impact of the opioid use disorder epidemic.